Understanding how evolutionary forces shape genomic imprinting and affect healthy development

SUMMARY
Genomic imprinting, the parent-of-origin-specific monoallelic expression of a subset of genes, is
critically important to human gene regulation and the healthy development of the embryo and
placenta. Proper regulation of imprinted gene dosage is a key challenge for assisted
reproductive technologies. Moreover, several human diseases that affect as many as one in ten
thousand live births result from genetic alterations that change the dosage of imprinted genes.
Although essential for development, imprinting is thought to evolve rapidly, raising the
possibility that the evolution of imprinting affects mammalian development and human
disease.
Despite a rich body of theory on the evolutionary forces that shape genomic imprinting,
almost nothing is known empirically, especially at the molecular level. My overarching goal is
to uncover the forces, mechanisms, and molecules underpinning the evolution of
imprinting, which will provide novel insights into how this important process works.
I will take two approaches to this question. First, I will leverage population genetic tools
and publicly available sequencing data to empirically characterize how these evolutionary forces
drive the evolution of genomic imprinting. Second, I will perform a focused experimental
dissection of disrupted imprinting in deer mouse hybrids. This work will be crucial for
understanding gene regulation across generations and within individuals.

Public health relevance
NARRATIVE For most of our genes, we express the copies we receive from both parents, but some genes are subject to genomic imprinting, a special type of intergenerational regulation of gene expression that specifies if a gene is expressed from the copy inherited from the mother or the father. Genomic imprinting is essential for healthy embryonic development, and mutations in this process cause several diseases; however, little is known about the evolutionary forces that shape imprinting. In this project, I will determine how positive and purifying selection shape genetic variation in imprinted genes and how genetic variation can lead to imprinting incompatibilities between parents.